Investigating the role of gut extracellular vesicles in diabetic peripheral neuropathy

Abstract
Peripheral neuropathy is one of the major complications of diabetes that greatly contribute to morbidity and
mortality. Currently, there is no effective treatment for diabetic peripheral neuropathy (DPN). Diabetes at an early
stage affects the intestinal microbial composition that promotes the manifestation of metabolic syndrome.
However, how gut dysbiosis contributes to the diabetic complications including DPN, is unknown. Extracellular
vesicles (EVs) mediate intercellular communication and bacterial EVs retain bacterial genetic and biomaterials.
Recent studies show that gut bacterial EVs participate in immune signaling pathways and host metabolic
homeostasis that are associated with many disorders. The impact of microbiota derived EVs on DPN has not
been investigated. Our preliminary studies demonstrate that gut bacterial EVs participate in the DPN progression.
Importantly, our preliminary data also indicate that Lactobacillus-derived EVs alleviate the systemic inflammatory
response, protect peripheral nerve damage, and improve neurorecovery in diabetic mice with peripheral
neuropathy. In this application, we propose to investigate the effect of gut bacteria-EVs on the development of
DPN and to examine the therapeutic potential of Lactobacillus-derived EVs and molecular mechanisms
underlying this therapy on neuroinflammation and peripheral nerve damage. These studies will not only
significantly expand our understanding of molecular mechanisms underlying gut microbiota-peripheral nerve
communication and progression of DPN, but also provide a novel and potentially useful treatment strategy for
patients with DPN.
.

Public health relevance
Project Narrative PUBLIC HEALTH RELEVANCE: Gut microbiota play a vital role in metabolism, endocrine, and immune system. Extracellular vesicles (EVs), small bilipid layer containers, mediate intercellular communication and hold great potential in drug delivery and therapy. We will investigate the novel role of gut microbiota-derived EVs in the progression of diabetic peripheral neuropathy (DPN), the most prevalent chronic complications of diabetes patients, and examine whether commensal beneficial microbiota-derived EVs can be employed as a potential therapeutic target against DPN and the underlying molecular mechanisms. Our work will provide new insights into the pathogenesis of DPN and may lead to the development of novel therapeutic agents for patients with DPN.